Ryanodine Receptor Defects in Cardiomyopathy Caused by Lamin A/C Gene Mutations

Project Summary
Dilated cardiomyopathy caused by mutations in the lamin A/C gene (LMNA) encoding A-type nuclear lamins is
a life-threatening disease with no definitive cure. The pathogenic mechanisms responsible for cardiomyopathy
in this inherited disease are poorly understood. In particular, it is not known how alterations in proteins
expressed in nuclei of virtually all terminally differentiated cells selectively cause heart disease. Our hypothesis
is that alterations in A-type lamins predispose cells to oxidative stress-induced remodeling of ryanodine
receptors (RyRs), creating a sarcoplasmic reticulum (SR) Ca2+ “leak.” Oxidative stress and increased cytosolic
Ca2+ also contribute to hyper-activation of extracellular signal-regulated kinases 1 and 2 (ERK1/2), which
occurs in cardiomyopathy caused by LMNA mutations. The increased cytosolic Ca2+ and ERK1/2 activity
generates various defects, including mitochondrial dysfunction, that cause cardiomyopathy. A corollary of our
hypothesis is that blocking the SR Ca2+ “leak” will have beneficial effects in cardiomyopathy caused by LMNA
mutations. Using mouse models of the disease and human tissue, we will test our hypothesis and its corollary.
In Aim 1, we will determine if alterations in A-type lamins that cause cardiomyopathy lead to enhanced cardiac
muscle oxidative stress, resultant RyR2 remodeling and a SR Ca2+ “leak.” We will also determine if the SR
Ca2+ “leak” stimulates ERK1/2 activity, causes mitochondrial dysfunction and damages DNA. In addition to
heart, we will similarly examine skeletal muscle, which is often simultaneously affected in human patients with
cardiomyopathy caused by LMNA mutations as well as in model mice. We will further assess these processes
in cultured cells that stably express a cardiomyopathy-causing lamin A variant or lack A-type lamins. In Aim 2,
we will utilize the three-dimensional structure of RyR to determine how specific oxidative modifications that
occur in striated muscle of Lmna mutant mice affect its structure and make it “leaky” to Ca2+. In Aim 3, we will
perform experiments to determine if a Rycal, drugs that stabilize remodeled RyRs and block the SR Ca2+
“leak,” improves heart function and prolongs survival in Lmna mutant mice and if it blocks the “leak” in hearts
from human subjects with cardiomyopathy caused by LMNA mutations. We will further determine if a Rycal has
synergistically beneficial effects when combined with an inhibitor of ERK1/2 activity, which has previously been
shown to partially improve heart function in Lmna mutant mice with cardiomyopathy. These studies will reveal
basic information about the pathogenesis of cardiomyopathy caused by LMNA mutations and connect an
intranuclear protein defect with a tangible mechanism of cardiac dysfunction. They will also determine if drugs
already in clinical development can be translated to trials in patients with this lethal heart disease.

Public health relevance
Relevance Mutations in the lamin A/C gene (LMNA) cause an inherited, severe dysfunction of the heart called cardiomyopathy. The goal of this project is to investigate a novel mechanism of heart muscle damage in this life-threatening disease and test new drugs for translation from the laboratory to patients.